IGF::OT::IGF

The Contractor will manufacture 1,000 hard gelatin capsules containing one to five (1-5) mg Aza-Td-Cyd (most likely higher than 1 mg) under cGMP condition for clinical use (The actual dose will be provided by the Project Officer upon sending API) . The formulation will be similar to 10 mg TD-Cyd capsules to fill a size 4 capsule, which color should be other than Swedish Orange. After QC release, testing please place 10 capsules per suitable size container and after inserting a pharmaceutical coil seal the container with induction sealer.